Re-purposing beta-blockers to improve chemotherapy response

ABSTRACT
Metastatic tumors often develop chemoresistance, which makes chemotherapy ineffective. We have exciting
evidence that beta-blockers, which are widely used cardiac drugs, can be repurposed to improve the effects of
chemotherapy. If we could understand how beta-blockers enhance the effects of chemotherapy, this would
expedite the translation of beta-blockers for treatment of patients with metastatic cancer, who are at high risk for
anxiety and depression and tend to have elevated levels of endogenous stress hormones including epinephrine.
Here we will test the hypothesis that beta-blockers can improve access of chemotherapy drugs to the tumor by
decreasing tumor density or stiffness to improve chemotherapy response. Our recent work shows that beta-
blockers modulate the physical tension of tumor cells. Building on these findings, we will test if beta-blockers can
be used to make tumors more porous to increase the delivery of chemotherapy drugs to tumor cells and enhance
the response of tumor cells to chemotherapy agents, paclitaxel and doxorubicin. We will also determine how the
effects of β-blockers on tumor cell chemosensitivity are modulated by matrix stiffness through RhoA and ROCK.
Beta-blockers are already well established for clinical use for heart disease, and are showing promising effects
on tumor biology in prospective clinical trials, which provides strong rationale for continued biological analysis of
the basic mechanisms involved to guide biomarker selection as this field advances toward Phase III clinical trials.
Repurposing beta-blockers to enhance chemotherapy response could thus have patient-related outcomes on a
short timescale of 5 years.

Public health relevance
PUBLIC HEALTH STATEMENT The primary goal of this research project is to introduce a novel treatment strategy to make existing chemotherapy treatment regimens more effective. We have evidence that beta-blockers, which are widely used cardiac drugs, can affect the physical properties of tumors. Understanding how we can harness beta-blockers to alter tumor physical properties and improve the delivery of chemotherapy drugs would expedite the translation of beta-blockers to achieve maximum benefit for patients with cancer.